LABORATORY EVALUATION OF GENE THERAPY FOR AIDS

To optimize isolation, transduction and expansion of lymphocytes from HIV-1 infected individuals under the conditions which will be used for a phase 1 study, to examine kinetics and stochiometry of ribozyme protection of primary cells, to determine if HIV antigen driven proliferation can be used to expand transduced cells, to obtain populations enriched in effector lymphocytes for reinfusion and to explore alternative methods of controlling HIV replication in infected cells during transduction of vectors.